ECOG-ACRIN Thoracic Malignancies Integrated Translational Science Center

PROJECT SUMMARY/ABSTRACT
The ECOG-ACRIN Thoracic Integrated Translational Research Center (EA-ITSC) comprises a team of
accomplished researchers with a proven track record of collaborative work to improve outcomes for patients with
lung cancer. The EA-ITSC, funded in 2014 by the NCI (U10) at the same time as the formation of the National
Clinical Trials Network (NCTN), has played a major role in developing novel approaches for risk stratification,
molecular testing, and treatment of lung cancer. This group has also been responsible for guiding the
development of biomarker-driven clinical trials initiated by the ECOG-ACRIN Thoracic Malignancies Committee.
Our highly collaborative team approach includes sharing specimens across institutions, conducting pilot projects
that are of direct relevance to NCTN trials and guiding the translational research components of all newly
developed ECOG-ACRIN thoracic malignancies trials. Our overarching goal is to develop novel biomarkers to
enhance the efficacy of immunotherapy, overcome resistance to targeted agents and to identify combination
treatment approaches to enhance the efficacy of existing therapies in lung cancer within the context of the NCTN.
With this application, we propose to continue our research work with direct relevance to the NCTN, with the
following specific aims: 1) To develop genomic, epigenomic, and proteomics approaches to enhance biomarker
discovery efforts in ongoing and planned ECOG-ACRIN studies; 2) To conduct pilot studies on existing ECOG-
ACRIN and institutional lung cancer tumor specimens that will lead to prospective NCTN clinical trials; and 3) To
guide the development of translational research components of ECOG-ACRIN Thoracic trials and promote
collaborations with lung cancer SPORE and P01 institutions. The EA-ITSC will have a robust pilot projects
program from years 2-6 of this award that will invite participation from all the NCTN network groups, institutions
with lung cancer SPORE and P01 awards, to bring the best science to NCTN clinical trials.

Public health relevance
PROJECT NARRATIVE The ECOG-ACRIN Integrated Thoracic Malignancies Translational Sciences Center brings together a team of outstanding researchers in both translational and clinical sciences to discover biomarkers and develop novel treatment approaches for lung cancer within the National Clinical Trials Network.